Outreach_Core

ABSTRACT: Education-Outreach Core
The primary goals of the Education-Outreach Core are to promote a better understanding of issues concerning
reproductive health and infertility in low income, underserved communities and by middle school, high school,
and community college students. We propose to continue a two-pronged approach to education and outreach
that we developed in the past grant period. First, we will continue and expand our collaboration with Urban
Impact of Pittsburgh. A central part of Urban Impact’s mission is to provide youth with the education and skills
to transition successfully from middle school to high school and into adult life. We will provide engaging half-
day Saturday Academy style hands-on laboratory experiences to teach reproductive biology and genetics to
high school students from Urban Impact (Aim 1a). We offered the “Sea Urchin Fertilization” lab and will
continue to teach this lab moving forward. The students collected sperm and eggs from sea urchins, mixed
them together in a petri dish, and used microscopes to visualize sperm swimming, sperm incorporation, sperm-
egg fusion, pronuclear migration and the first cell divisions in the developing embryo. More recently, we offered
a lab using worms (c. elegans) as a model to study genetics and meiosis. We have partially developed 3 new
labs that will also be deployed for Aim 1a. As a result of participating in these highly successful lab
experiences, youth at Urban Impact requested that our P50 program participate in their job training program
(Jobs Inc.) so select students could gain further hands-on laboratory experiences while getting paid as part-
time employees, which we propose in Aim 1b of this renewal. We will also make the labs we develop and
refine available on a new website and at teacher workshops (Aim 1c). Second, we will continue and expand
our collaboration with The DataJam, a nonprofit organization that runs a nationally available academic
education program and competition to engage middle school, high school and community college students in
learning data analytical skills and appreciating how valuable data and critical thinking skills are for virtually all
career paths. DataJam teams formulate a research question, find publicly available data sets, analyze data
and present their findings to a panel of judges. Over the past grant period P50 graduate students have
developed DataSet Guides (that are freely available on the DataJam website) on “Male Reproduction &
Infertility”, “Sexually Transmitted Diseases”, “Contraceptives”, “Gender Inclusive Health Care”, “Screening
Newborns for Disease”. In this grant period we will develop new DataSet Guides on a variety of topics in
reproductive biology and genetics (Aim 2a), train P50 students and fellows to become DataJam mentors (Aim
2b), and train teachers to guide projects in these areas (Aim 2c).